Computational and translational motor control

DESCRIPTION (provided by applicant): The proposed symposium entitled Computational and Translational Motor Control (CTMC) will happen in the autumn of 2013. Its objective is to facilitate the information transfer between scientific communities studying computational motor control (mathematical movement science) and those scientists working on making an impact on translational motor control (bench to bedside). This is important for the mission of the NIH, as it enables research that promises to improve the lives of many patients suffering from neuromotor diseases.

Public health relevance
Having a symposium combining the most current research in computational motor control and also state of the art translational research in motor control promises to lead to breakthroughs for many patients with movement diseases. The rapid progress in the computational field could be translated into breakthroughs for patient treatments. This includes many clinical areas including stroke, Parkinson's disease, aging, and promises to facilitate the transition to individualized medicine. NOTE: The critiques and criterion scores from individual reviewers are provided below in an essentially unedited form. These were prepared prior to the review meeting and may not have been updated or revised subsequent to the discussion at the meeting. Therefore, they may not fully reflect the final opinions of the individual reviewers at the close of group discussion or th final majority opinion of the group. The Resume and Summary of Discussion above summarizes the final outcome of the group discussion.